Tissue Based Small Animal Model for HIV Drug Discovery

The objective of this contract is to further the preclinical development of novel therapies (low molecular weigh organic molecules, biologics, and engineered viruses) for HIV- 1 through pre-clinical testing in the well characterized SCID-hu Thy/Liv modle small animal model. The major scientific functions of this contract are listed below: 1. Evaluate HIV therapeutics in an in vitro model 2. Evaluate potential HIV-1 therapeutics in vivo in a validated small-animal model 3. Maintain quality control/assurance of viral stocks, donor tissue, and reconstituted immunodeficient mice 4. Further characterize or develop the animal model and adapt newly discovered models 5. Collect samples of animal tissues and/or fluids and prepare such samples for shipment